Investigating the Neuronal Signals Initiating Synapse Loss in Aging and Alzheimer's Disease

Abstract: Late-onset Alzheimer’s disease (LOAD) targets the association cortices to cause profound
dementia, and available treatments do not alter disease progression. The greatest risk factor for LOAD is
advanced age, yet it is unknown why the aging association cortices are vulnerable to degeneration. Cognitive
impairment tightly correlates with synapse loss in the dorsolateral prefrontal association cortex (dlPFC), which
subserves higher-order cognition. Mouse models have shown that microglia can remove synapses by
interacting with molecular “tags” on neurons, including complement (C1q) and phosphatidylserine (PS).
However, it is unclear what upstream changes within neurons trigger the generation of these molecules, and
whether these mechanisms are activated in the aging dlPFC. The proposed research will utilize an aged
rhesus macaque model with mechanistic in vitro experiments, to identify the intraneuronal mechanisms that
contribute to synapse loss in the aging association cortex. Aging rhesus macaques have an expanded dlPFC
and naturally develop cognitive deficits, plaques and tangles, complement C1q expression, and region-specific
synapse loss. Aged macaques also develop an abnormal mitochondrial phenotype termed “Mitochondria-on-a-
string” (MOAS) that is seen in human LOAD. I hypothesize that MOAS may arise from chronic calcium (Ca2+)
overload of mitochondria, generating molecules participating in synapse removal, including activated C1q, PS,
and Caspase 3. Synapses in dlPFC are especially vulnerable to Ca2+ dysregulation as they express cAMP-
protein kinase A (PKA) signaling to magnify internal Ca2+ release through ryanodine receptor 2 (RyR2) and
inositol triphosphate receptor type 1 (IP3R1). This process is regulated by the phosphodiesterase PDE4D in
young brain, which is lost with advancing age. I hypothesize that sustained elevations in cytosolic calcium
leads to Ca2+ overload of mitochondria and the induction of MOAS with advancing age, leading to the
expression of molecules (C1q, PS, and cleaved caspase 3) that mediate synapse removal by nearby microglia.
Aims 1 and 2 will utilize high resolution immuno-Electron Microscopy (EM) and 3D EM reconstruction to
elucidate the interactions between MOAS, and (Aim 1) molecules known to mediate synapse removal, and
(Aim 2) markers of Ca2+ dysregulation in the dlPFC of young vs. aged macaques. Preliminary data indicate that
MOAS preferentially associate with C1q and are more frequent under conditions when PDE4D expression is
absent. Aim 3 will use primary murine cortical neuron cultures, immunofluorescence, super-resolution
microscopy, and biochemistry to model Ca2+ dysregulation in vitro and test whether chronically elevated Ca2+
levels can induce the MOAS phenotype and generate the molecules mediating synapse removal. Relevant in
vitro findings will be cross-validated in the macaque tissue. Identification of the intraneuronal events that lead
to synapse loss in the vulnerable aging cortex will provide key insights into how advancing age contributes to
LOAD pathogenesis, and help identify potential targets for early therapeutic interventions.

Public health relevance
Project Narrative: Cognitive decline is a clinical hallmark of late-onset Alzheimer’s disease (LOAD), costing millions of elderly individuals’ quality of life years. Synapse loss is highly correlated with cognitive decline, and seen early in LOAD and aging; while potential neuronal-microglial interactions mediating this loss have been identified, it remains unknown how these interactions are triggered in aging and confer vulnerability to LOAD. This proposal will elucidate specific upstream, age-related neuronal calcium and mitochondrial dysregulation that may trigger synapse loss, providing potential key therapeutic targets to preempt cognitive decline, and thus extending the number of healthy, active years of life.